RECOMBINANT &PLASMA DERIVED HUMAN FACTOR IX GLYCOSYL COMPOSITION ANALYSIS

The glycoprotein, human Factor IX, from recombinant and natural sources was analyzed for monosaccharide composition by preparing the TMS derivatives of the methylglycosides followed by GC and combined GC/MS analyses. TMS methylglycosides were prepared from the sample by methanolysis in 1 M HCl in methanol followed by N-acetylation with pyridine and acetic anhydride. Inositol was added to the sample before derivatization as an internal standard, and a number of n-alkanes were co-injected as retention standards for the GC analysis. The monosaccharides were identified by their retention times in comparison to standards, and their carbohydrate character was authenticated by their mass spectra.